SOLID STATE STUDIES OF PHYSIOLOGICALLY IMPORTANT MOLECULES

Work consists of solid state and computational investigations of structure, conformation and configuration of biologically important molecules. Compounds investigated were relevant to AIDS therapy, biological membranes, synthesis, and cancer therapy.